Subtyping COre for Research on the Etiology of Type 2 Diabetes (SCORE-T2D)

PROJECT SUMMARY
Type 2 diabetes (T2D) is one of the fastest growing chronic diseases worldwide and is a leading contributor to
comorbidities and early mortality. Current prevention and treatment strategies are not optimal for all individuals
due to heterogeneity in the etiology and pathophysiology of T2D. Indeed, substantial variation exists across
individuals in the relative contribution of insulin resistance vs. beta cell function to T2D development and
progression, as reflected by differences in glucose regulation among persons with comparable glycemia at
diagnosis. Recent research has applied clustering algorithms to identify subgroups of diabetic individuals with
varying clinical profiles, risk of diabetes complications, and responsiveness to treatment therapies based on
clinical variables measured at diagnosis (e.g., body mass index, age, fasting glucose and insulin, hemoglobin
A1c, diabetes autoantibodies). Most of these studies leveraged large registry-based European cohorts, which
boast large sample sizes but lack diversity and/or data on social determinants of health that are known to drive
chronic disease risk in the U.S. Moreover, most subtyping methods that have been applied require subjects to
be placed in fixed categories which may not reflect the racial/ethnic and sociodemographic diversity of U.S.
populations and may not be ideally suited to accommodate mixed data types (e.g., clinical, omics, behavioral,
environmental, social). Such multimodal data provide an untapped opportunity for subtyping based on realistic
multi-level drivers of heterogeneity in the clinical course of T2D, from prediabetes to complications and
comorbidities. In response to RFA-DK-23-020, we seek to establish the Subtyping Core for Research on the
Etiology of Type 2 Diabetes (SCORE-T2D) at the University of Colorado Anschutz Medical Campus. Partnering
with the Consortium, SCORE-T2D will lead innovative analytic activities and provide crucial resources for the
Consortium Cohort Sites through methodological expertise in subtyping algorithms, data harmonization across
large datasets, single and multi-omics analyses, lifecourse epidemiology, and integration of social factors;
content expertise in T2D etiology and pathophysiology; and programmatic experience in multi-site study
coordination and analyses. Our overarching objective is to work with the Cohort Sites and NIDDK to employ
multi-level, multi-dimensional approaches to characterizing heterogeneity in T2D in the Consortium. We will
accomplish this through 1) developing and implementing consensus protocols for data sharing, management,
harmonization, and analysis; 2) characterizing subtypes of T2D and identify underlying social and physiologic
drivers of the etiology and clinical course for each subtype; and 3) coordinating Consortium logistics on results
sharing, outreach, and dissemination. SCORE-T2D at the University of Colorado Anschutz Medical Campus will
bring a fresh perspective on multi-site coordination and biostatistical expertise by spearheading efforts to quantify
and understand heterogeneity in the risk factors, pathophysiological mechanisms, manifestations, and
consequences of T2D.

Public health relevance
PROJECT NARRATIVE Capitalizing on the pre-existing infrastructure for multi-site analysis and study coordination at the University of Colorado Anschutz Medical Campus, the investigative team will establish the Subtyping Core for Research on the Etiology of Type 2 Diabetes (SCORE-T2D) biostatistics research center. SCORE-T2D will work with the Cohort Sites and NIDDK to employ multi-level, multi-dimensional approaches to characterize heterogeneity in type 2 diabetes in the Consortium. Establishment of SCORE-T2D and completion of the proposed goals will result in a broadly applicable framework for identifying type 2 diabetes subtypes and forge new research opportunities for effective precision interventions to prevent, reroute the clinical course, and optimize long-term prognosis of type 2 diabetes in diverse populations.